Dissecting the roles of timing in a canonical neural computation

Project Summary [30 lines max]
Timing is critical to neural processing. Nowhere is that clearer than in visual motion detection. To detect
motion, neurons transmit visual information with different latencies, or delays, allowing the circuit to compare
visual scenes over time. When comparisons over time are combined with comparisons over space, the circuit
can compute direction-selective signals, which are larger for motion in one direction than in the opposite
direction. These signals in turn guide a wide range of behaviors, from navigation and predator avoidance to
mating. This project proposes to investigate the origins and effects of timing differences in visual motion
circuits in the fruit fly Drosophila, a model organism in which powerful genetic tools can identify the roles of
individual neurons in computations. Using these tools, this research will identify mechanisms that underlie the
different dynamical responses of visual neurons and map out how those responses control downstream
computations. This work is significant for two reasons. First, motion detection is a canonical neural
computation, since it requires circuits to integrate visual information over both time and space, and because it
is necessarily nonlinear. Moreover, the anatomy, physiology, and computational structure of motion detection
has strong parallels between flies and mammalian retina and cortex. Therefore, it is likely that what we learn
about the mechanisms that regulate timing the fly eye and their effects on motion computation will be mirrored
in other circuits that detect visual motion. Second, our proposed aims will test fundamental models of motion
detection. All of these models rely on timing differences that permit comparisons to be made over time, but
these assumptions have not been tested. Our research will distinguish between proposed models in the fly and
test fundamental assumptions about how motion is computed by differences in the timing of neural signals. In
our complementary aims, we will uncover mechanisms that generate different timing in different neural
responses. We will also measure the effects of timing differences on motion signals and on behavior. On
completion, these studies will advance our understanding of how neural response timing is regulated and how
that timing determines downstream neural computations. We expect that what we learn in this small neural
circuit can serve as a scaffold for understanding the roles of timing in motion detection in the larger brains of
mammals.

Public health relevance
Project Narrative: Relevance of the research to public health; no more than 2-3 sentences of text. This research investigates how the timing of different neurons is regulated and contributes to computing visual motion. Since timing is essential to all visual processing, we must understand how it is regulated if we are to understand and treat visual impairments and blindness. Timing is also essential to neural processing beyond vision, so advancing our understanding of timing in neural circuits will help us to understand and treat disruptions in function brought on by disease.